Racial Inequities in Opioid Overdose Prevention: The role of local context in the effectiveness of state-level overdose prevention policies

Deaths due to opioid overdose are a pressing public health crisis and the number of deaths per
year is increasing, largely driven by the increased prominence of synthetic opioids. Interventions
are critically needed that can effectively reduce overdose mortality. Overdose prevention policies
(OPPs) (i.e., Good Samaritan laws and naloxone access laws), a class of state-level policy
interventions intended to reduce overdose mortality, may be able to address rising fatal overdose
rates. However, there are critical gaps in the literature regarding the effectiveness of OPPs,
including a lack of prior research into which provisions may better reduce overdose deaths across
different jurisdictions, and a lack of prior research into the extent to which local contextual factors
modify the effects of state-level OPP provisions. Additionally, the common practice of enacting
OPP provisions in packages creates a significant methodological challenge for standard causal
inference approaches of assessing the effectiveness of individual OPP provisions. The scientific
objective of this research plan is to assess the effectiveness of state-level OPP provisions to
reduce overdose mortality and identify local-level factors that may produce varying effectiveness
of provisions. This project uses novel causal machine learning methods in conjunction with a
combination of restricted mortality data from the National Vital Statistics System and multiple
publicly available data sources to address the methodological challenge and fill the critical gaps
outlined above. This innovative data-driven approach will be complemented by taxonomies of
hypothesized OPP provision effectiveness produced by a panel of opioid policy experts using the
Delphi method. By doing so, this project will empirically evaluate which sets of OPP provisions
are most effective at reducing overdose mortality and estimate the role of local contextual factors
(e.g., access to harm reduction services or local law enforcement practices) in producing varied
effects of OPP provisions. This research plan is complemented by a career development plan
that builds upon the applicant’s background in epidemiology and biostatistics and includes new
training in (1) development and implementation of state-level drug policies; (2) measurement and
evaluation of policy intervention effectiveness; and (3) machine learning methods to identify
salient causal measures from high-dimensional data. The combined research and training plan
will prepare the applicant to successfully transition to an independent research career aimed at
using novel statistical and computational methods to identify and evaluate interventions to reduce
substance use related harms.

Public health relevance
Deaths due to drug overdose continue to be a pressing public health crisis as more than 1,000,000 people have died of overdose in the United States since 1999. Interventions are critically needed that can effectively reduce overdose mortality. This project will fill important gaps in the evidence for effectiveness of overdose prevention policies to reduce rates of fatal overdose and will provide information that will help policymakers determine which policy tools may be best suited to address the overdose crisis.